Genomics of Cardiac Arrhythmias

Project summary
Cardiac arrhythmias are prevalent and are associated with substantial morbidity and healthcare utilization. In
particular, supraventricular tachycardias and bradyarrhythmias are common causes of palpitations and
syncope, and may lead to sudden death in some circumstances. Many treatments for these conditions are
incompletely effective or associated with potential adverse effects. Despite the recognized public health
importance of arrhythmias, there is a limited understanding of their mechanisms.
Our overall goals are to identify the causes of arrhythmias and improve treatments for affected patients.
The specific objective of this proposal is to leverage large-scale human genetic association studies to
understand the mechanisms of both supraventricular tachycardias and bradyarrhythmias. The proposal
is motivated by three key observations.
First, monogenic forms of supraventricular tachycardias and bradyarrhythmias, familial aggregation of
these arrhythmias, and preliminary data identifying common variation associated with these conditions all
indicate that there is a substantial genetic basis for supraventricular tachycardias and bradyarrhythmias. Yet
genome-wide association studies, a highly efficient method for understanding human disease, are lacking for
these conditions. Second, we have substantial experience with collaborative genetic association analyses of
arrhythmias, and have established the Arrhythmia GENetics (AGENT) neTwork, a multi-site consortium of
investigators that will contribute samples for the proposed aims. Third, our team is comprised of experts in
complex trait and arrhythmia genetics who have developed innovative methods to enable functional
characterization of identified genetic loci.
The applicant is an Early Stage Investigator with experience in arrhythmia genetics. In Aims 1 and 2
of the current proposal, we will identify genetic susceptibility loci associated with supraventricular tachycardias
and bradyarrhythmias by performing genome-wide association studies in well-characterized individuals. In Aim
3 we will quantify the aggregate genetic contributions to supraventricular tachycardias and bradyarrhythmias,
systematically assess the genetic architecture of these arrhythmias, and estimate the genetic correlation of
arrhythmias and related phenotypes. In Aim 4, we will move from association to mechanism by characterizing
the electrophysiological phenotype of the top supraventricular tachycardia and bradyarrhythmia genes in stem
cell-derived cardiomyocytes, a zebrafish model system, and by cellular electrophysiology.
We anticipate that our multi-faceted approach will facilitate an improved understanding of the causes of
arrhythmias. Such insights may lead to novel therapeutic approaches for patient management and a
comprehensive understanding of cardiovascular biology relevant to the broader scientific community.

Public health relevance
Project narrative Cardiac arrhythmias impose a substantial public health burden, yet there is a limited understanding of the mechanisms leading to these conditions. Motivated by preliminary data, we seek to leverage large-scale human genetic analyses to understand the biological mechanisms of two leading classes of arrhythmias – supraventricular tachycardias and bradyarrhythmias. The insights gained from the proposed aims will lead to a greater understanding of the causes of arrhythmias, which may lead to novel therapeutic approaches and a comprehensive understanding of cardiovascular biology relevant to the broader scientific community.